4th National Conference on Per- and Polyfluoroalkyl Substances – Environmental Justice and Scientific Discovery

PROJECT SUMMARY/ABSTRACT
Per- and polyfluoroalkyl substances (PFAS) comprise a class of several thousand compounds
that present a major public health problem worldwide. The 4th National Conference on Per- and
Polyfluoroalkyl Substances – Environmental Justice and Scientific Discovery, will be held in Ann
Arbor, MI, a region affected by PFAS drinking water contamination, to continue growing the
impact of the conference by facilitating PFAS information sharing and collaborative research
and remediation across the country. This meeting uniquely convenes scientists, government
officials, environmental justice activists, affected community members, journalists, utility
managers, and lawyers to support and better inform the priorities of diverse PFAS sectors. It
also cultivates new cross-sector collaborations to help prevent future PFAS contamination and
exposure-related health risks, and leverages a diversity of perspectives to more effectively
prevent future exposure and protect human health.

Public health relevance
NARRATIVE Per- and polyfluoroalkyl substances (PFAS) comprise a class of several thousand compounds that present a major public health problem worldwide. The 4th National Conference on Per- and Polyfluoroalkyl Substances – Environmental Justice and Scientific Discovery, will be held in Ann Arbor, MI, a region affected by PFAS drinking water contamination. This meeting will uniquely convene scientists, government officials, environmental justice activists, affected community members, journalists, utility managers, and lawyers to examine the complex set of social, scientific, political, and environmental health issues associated with PFAS exposure and to cultivate cross-sector collaborations to more effectively prevent future exposure and protect human health.